Cell Biology Core

PROJECT SUMMARY – CELL BIOLOGY CORE
Cell Biology has been a component of the DRTC since its inception in 1977. It has taken many forms
over the past 40 years, most recently focusing on studies of pancreatic islets and beta cells. However,
in the past 18 months and in this application the Cell Biology Core has been broadened to also include
studies of adipocytes, hepatocytes, and innate and adaptive immune cells from normal and diabetic
humans and mice. The Core provides a broad range of services in cell-based systems to understand
the roles of islet endocrine cells, adipocytes, hepatocytes and immune cells in health and disease with
an emphasis of studies using primary cells from humans and mice. The Core provides advice on study
design, methods and data interpretation. Since many of the techniques are new to investigators, it also
provides direct hands-on support and training to ensure the successful and timely completion of
experiments. This Core is centered at the University of Chicago and the University of Illinois at Chicago.
The two groups meet regularly and have developed standard operating periods to ensure that Users
receive quality support for their studies. The Core also has an ongoing commitment to training and has
trained investigators, fellows, students and research technicians in the procedures of the Core. The Cell
Biology Core is an integral part of the DRTC, and thus synergizes with the Circadian Biology and
Physiology Cores, by facilitating diabetes based research on primary cells and tissues from mice and
humans. Moreover, it allows discoveries made in the Genetics and Genomics Core to be tested in a
biological context.